Synthetic biology and organelle genomics: A rubisco library as a case study in evolutionary landscapes and organellar engineering

Food security is a critical issue facing human health in the 21st century as the global population
approaches 10 billion and climate change threatens the food supply. Photosynthetic engineering has
been successful in improving crop yields but the central enzyme of carbon fixation, rubisco, has
remained intractable as a target of molecular evolution. The few plants tested with heterologous
rubiscos grow uniformly slower than their wild-type counterparts. The goal of this proposal is to
generate a chloroplast genome library in plants to explore the limits of rubisco function and
organellar genome organization.
In Aim 1 of this proposal I will explore the sequence-function landscape of a model, homodimeric
rubisco enzyme and a novel, linked variant I have generated. I have generated a deep-mutational
scan (OMS: all possible point-mutants) library and will assay their function in a uniquely suited
rubisco-dependent E. coli strain. I have shown that these linked rubiscos function in vivo and in
vitro and have already constructed the mutant library; in the K99 phase of this project I will
perform selections on this library and analyze the data with a machine learning model. In the R00
phase I will generate further libraries to explore regions of the sequence landscape predicted to
be rich in improved rubiscos with the goal of testing them in plants.
In Aim 2 I will improve chloroplast transformation technology in order to enable the generation of
chloroplast genome libraries of unprecedented size in the chloroplast-editing model plant N.
tabacum. To do this I will generate sequence-specific TALEN nucleases that will be expressed from
the nuclear genome and trafficked to the chloroplast where they will cut and disrupt the genome,
preferencing homologous recombination of transgenic donor ONA. After demonstrating TALEN-cutting in
the K99 phase I will develop this technology into an intracellular gene drive which will accelerate
chloroplast genome editing.
In Aim 3, with the technology developed in Aim 2 and the rubisco variants discovered in Aim 1, I
will generate libraries of plants with altered rubisco genes and promoters in order to demonstrate
the potential of rubisco engineering to improve plant growth. In addition, in the R00 phase, I will
produce a comprehensive chloroplast gene knockout library in order to answer fundamental questions
about the evolutionary flow of genes from organellar genomes to nuclear genomes.
My goal as an independent investigator is to study organellar biology in model plants in order to
explore the limits of engineering in individual proteins and metabolic pathways. My training in
organellar transformation, protein library generation and laboratory management during the K99
phase will prepare me well for the R00 phase. The Innovative Genomics Institute at UC Berkeley and
the laboratories of Ors. Oavid Savage and Brian Staskawicz in particular are the ideal environment
for my career transition, combining precisely the necessary mixture of expertise - protein
evolution and plant transformation, respectively.

Public health relevance
The goal of this proposal is to overcome the fundamental limits of the carbon-fixing enzyme rubisco and to translate that knowledge into improvements in carbon fixation efficiencies in transgenic plants. By studying a wider array of genes, gene variants and expression levels, the chloroplast transformation technologies proposed here have the potential to reshape our understanding of the limits of photosynthetic yield in plants. Insights from this work will advance basic and applied biology fields including metabolic control, protein evolution, biochemistry, organellar genome organization and genome editing.